Program in Biomedical Sciences

The Program in Biomedical Sciences (PBMS) is a new degree-granting interdisciplinary program designed to
provide rigorous training in molecular, biochemical and cellular biology for trainees pursing a career in
research-related disciplines. It replaces our prior NIGMS-funded program with substaintial curricular reform
designed to meet the needs of the current biomedical research workforce. PBMS provides high quality didactic
training that includes scientific content interwoven with elements that enhance the development of professional
skills and ensures the highest standard of research training. PBMS is comprised of six research hubs focused
on 1) Biochemical, Molecular and Structural Biology; 2) Chemical Physiology; 3) Differentiation, Development
and Disease, 4) Genome Sciences; 5) Integrated Cancer Biology; 6) Infectious Disease and Immunology.
These hubs provide intensive academic environments that are reflective of research strengths at OHSU and
facilitate the training needs of our diverse group of students. Hubs are populated by highly dedicated faculty
and trainees at all levels to create inspiring research training opportunites. The mission of PBMS is to train
students from a diversity of personal backgrounds and biomedical disciplines so they are prepared to
successfully enter the biomedical research workforce. Associated with PBMS is this proposed T32 program,
which is fully integrated into the PBMS structure. It brings added value through new experiential learning and
career development opportunites, and creating a growing cohort that fosters inclusiveness. The overarching
objective is to provide high-quality research training and facilitate transition into a variety of potential careers.
This is supported by curricular reform that includes mentored research experiences, interdisciplinary scientific
research training, experiential professional training, and an environment that enhances opportunities for
collaborative work. The objectives of the program are: 1) Provide trainees with the specific skills they need to
successfully enter the biomedical workforce in the field of their choosing. This includes activities that inform
students about career opportunities, how to prepare for their career choice, and networking opportunities to
facilitate career entry; 2) Enhance the training environment to become more inclusive and supportive, with the
goal of building and sustaining diversity at all levels in our program; 3) Expand the highly collaborative nature
of our research enterprise by encouraging trainee involvement in identifying and participating in new
collaborations; 4) Reduce time to completion from the current average 5.6 years to 4.5 years, which is
addressed by substantial curricular reform; 5) Increase the completion rate for all trainees. In the past 5-years
98% of well-represented trainees but only 85% from underrepresented groups completed the PhD. Improved
retention is based on efforts to build a more inclusive training environment that supports and values diversity at
all levels. Trainees from this program will enter the biomedical research workforce with the expertise in a basic
biomedical discipline and skills to independently acquire knowledge to advance their chosen field.

Public health relevance
The purpose of this proposal is to provide training in professional skills to a diverse group of PhD students in cellular, biochemical and molecular biology research that will enhance their ability to develop into independent scientists with careers in biomedical research-related fields. In addition to rigorous training in cellular and molecular-based scientific disciplines, the students will be involved in experiential learning in scientific communication, networking and mentoring, and career development. The goal is to prepare these trainees to become leaders in the scientific workforce in a supportive, safe, inclusive and academically rigorous environment.